GERIATRIC LEADERSHIP ACADEMIC AWARD

This is an application for a Geriatrics Leadership Academic Award. In the application, the candidate describes activities to promote, coordinate and enhance aging research and research training at The Medical College of Pennsylvania. To accomplish this, the candidate will: (1) Develop a campus-wide Center as the focal point for communication and coordination of activities in aging. (2) Organize and promote collaborative research projects including basic science and clinical science projects. (3) Develop and promote a multidisciplinary pilot research program on aging. (4) Develop research training programs on aging including NIA Complementary research training grants for training grants already in existence at The Medical College of Pennsylvania and summer research fellowships for medical students. (5) Promote the expansion of resources for research on aging at The Medical College of Pennsylvania. (6) Expand his breath and depth in gerontology and geriatrics by continuing to learn molecular biology and its application to the problems of aging and by consulting with the directors of outstanding geriatrics programs to become better acquainted with the design and function of successful programs. This experience will enable the candidate to help in the planning process for the expansion of the Geriatrics Program at The Medical College of Pennsylvania.